Using behavioral economic domains to characterize cannabis use trajectories among young adults: A prospective mixed-methods investigation

PROJECT SUMMARY
Young adulthood (ages 18-25) is a critical developmental period during which individuals often escalate or
mature out of substance use. Indeed, young adults (YA) use cannabis at the highest rate of any age group, with
35% reporting past year use, thus it is critical to identify factors associated with hazardous cannabis use given
the potential impact on this vulnerable developmental group. Heavy cannabis use among YA is related to poorer
health later in life, deleterious long-term effects on cognition, engagement in hazardous behaviors while under
the influence (e.g., driving), and myriad other cannabis-related problems. As such, it is imperative to understand
factors that influence the time course of cannabis use patterns and mechanisms underlying transition from casual
to heavy or hazardous use levels. Notably, young adulthood is characterized by frequent, smaller-scale
transitions (i.e., micro-transitions) and critical life events that can lead to an escalation or reduction in cannabis
use, likely depending on their subjective evaluation (i.e., valence). Certain transitions may increase cannabis
use frequency (e.g., college entrance), while others may be protective (e.g., marriage). A behavioral economic
(BE) framework can help explain how micro-transitions during young adulthood influence prospective changes
in cannabis use. BE domains are influenced by internal (e.g., craving) and external (e.g., new employment)
influences and include (1) access to and preference for alternative reinforcers (i.e., lack of alternative activities
that compete with cannabis), (2) discounting of delayed rewards (i.e., inordinate preference for smaller
immediate rewards, such as positive cannabis effects), and (3) relative cannabis value (i.e., demand; willingness
to pay prohibitively high prices for cannabis despite limited resources or income). Further, motives for cannabis
use (e.g., coping, enhancement) are key variables that likely account for the relation between micro-transitions
and changes in cannabis use among YA as well. Investigating factors that relate to escalation or reduction in
cannabis use are of clear

Public health relevance
PROJECT NARRATIVE In the wake of more permissive cannabis laws, availability, and positive normative perceptions, cannabis use prevalence during young adulthood continues to rise, and heavy use confers risk for cannabis-related problems and poorer health later in life. Young adulthood is typified by frequent, small-scale transitions, yet it is unclear how these micro-transitions confer risk (or resilience) for subsequent cannabis use, and underlying mechanisms linking the two remain poorly understood. To address these gaps, this proposal will use a 3-year prospective mixed-methods design to assess young adult micro-transitions, cannabis use patterns, and mechanisms linking these two constructs, which will ultimately inform future development of prevention and intervention efforts for young adults with hazardous cannabis use.